Remyelination in a mouse model of multiple sclerosis resulting from microbial metabolite sensor disruption

ABSTRACT:
Multiple sclerosis (MS) is a debilitating and complex autoimmune disorder in which the myelin within the
central nervous system is attacked. The frequency and severity of relapses are highly variable and are linked to
both environmental and genetic etiologies. Compelling data obtained from patients and animal models of MS
show that the gut microbiome is a critical mediator of pathogenesis. While the relationship between the
commensal microbiota and the immune system is well established, the precise mechanisms underlying
microbiota-immune crosstalk seen in MS remain unclear. In this proposed study, I suggest a mechanistic link
between microbiome and myelin recovery in a mouse model of MS, experimental autoimmune encephalomyelitis
(EAE). A sensor of microbial metabolites called the aryl hydrocarbon receptor (AHR) is a transcription factor
that modulates immune and metabolic homeostasis at barrier tissues including the skin, lungs, and, importantly,
the gastrointestinal tract. AHR activity in T cells has the capacity to modify the gut microbiome as well as modify
immune cell fitness. Previous work has focused on germ-line AHR knockouts or cell specific knock out in the
nervous system; however, I have produced a CD4 T cell specific AHR knockout mouseline, and these animals
exhibit a microbiome-dependent recovery from EAE. These mice have increased myelin coverage after initial
paralysis and decreased IL-12 in the spinal cord at peak of disease. Additionally, I have found that IL-12 reduces
oligodendrocyte progenitor cell (OPC) differentiation into myelinating oligodendrocytes in vitro. Under this
proposal, I aim to use my previously described model of recovery, T cell Ahr knockout mice, to 1) characterize
the myelin dynamics in a remyelinating lesions and 2) determine the role of IL-12 as an intermediary between
the immune system and myelinating oligodendrocyte progenitor cells. I will determine whether myelin recovery
is the result of OPC differentiation or of mature oligodendrocyte recovery using transmission electron microscopy
and lineage tracing. I will attempt to understand the source of the IL-12 in this model and the cell intrinsic signaling
cascades in OPCs and oligodendrocytes affected by IL-12. Finally, I will utilize an IL-12 receptor knockout to
understand the role of IL-12 during myelination in vivo. Understanding this mechanistic link between the
microbiome and the central nervous system will have implications for early stage MS patients recovering from
relapsing symptoms. By establishing the direct and indirect effects of an environmental sensor (AHR) on the
spinal cord microenvironment, we can better understand the underlying basis of recovery in MS and identify
more targeted therapeutics, thus avoiding the current approach of systemic immunosuppression.

Public health relevance
PROJECT NARRATIVE: Multiple sclerosis (MS) is a demyelinating autoimmune disorder in which the microbiome educates the immune system, in turn, determining the severity and scale of myelin destruction. The aryl hydrocarbon receptor (AHR) regulates immune activation in response to microbial metabolites; but also feeds back on the microbiome allowing promotion of an anti-inflammatory environment. In this proposal, I aim to establish how remyelination occurs in a CD4+ specific Ahr deficient animal that recovers from EAE.